Biostatistics and Neuroinformatics (BNI) Core

The Biostatistics & Neuroinformatics (BNI) Core serves as a centralized resource for biostatistical consulting and data management for all scientific projects proposed in this application. The core serves as a resource for data management and quality control, through a set of comprehensive neuroinformatics tools. The core personnel provide support to each of the junior principal investigators (PI) at all levels of investigation, beginning with the formulation of specific hypotheses, reviewing the design of studies, and evaluating the utility of measurement techniques. Support and consultation continues with the interpretation, presentation, and publication of the results, as well as throughout the grant application process.